Cytokine regulation of skin barrier function

PROJECT SUMMARY/ABSTRACT
Atopic dermatitis (AD) is a chronic relapsing inflammatory condition of the skin that results from the interactions
of the immune system with the structural cells in the skin. Cytokines produced by Th2 cells are critical
promoters of atopic inflammation, and biological therapeutics that block the effects of IL-4, one of the Th2
cytokines, are efficacious in treatment of AD. Mechanistically, IL-4 potentiates inflammation by promoting
chemokine production allowing increased recruitment of cells to the inflamed tissue, decreases expression of
genes in keratinocytes that contribute to barrier function, and impairs innate pathogen defenses in the skin. We
have added to our understanding of this process by demonstrating the ability of IL-4 to impair re-
epithelialization of the skin after wounding. In a disease that is perpetuated by an itch-scratch-wound cycle, the
inability to recover from wounds and restore barrier function is a critical component of chronic disease. Among
the discoveries in our previous cycle of funding we demonstrated that keratinocytes exposed to IL-4 have
impaired wound-healing responses both in vitro and in vivo using a model of atopic dermatitis. IL-4 stimulation
repressed fibronectin expression in keratinocytes, and supplementing fibronectin either to cultures, or topically
to wounded tissue in models of AD. Importantly, while wound healing has been studied extensively, how the
atopic environment alters wound healing is completely unknown. In the next funding period we will define a re-
epithelialization regulatory circuit that involves IL-4, γδ T cells, keratinocytes, and fibronectin. Experiments in
the First Aim will define the IL-4-responsive cells that contribute to altered wound healing in models of AD.
Based on preliminary data that there is a dramatic loss of γδ T cells in the skin of AD models, the Second Aim
will determine how the γδ T cell contribution to wound healing is altered in an atopic environment. The final
Third Aim will focus on testing the efficacy of topical fibronectin application in human skin transplant models.
Together, the studies in these Aims will mechanistically define the interactions of immune and structural cells
during a wound healing response in the context of an atopic environment, and will test potential new
approaches to treating the pathology in AD.

Public health relevance
PROJECT NARRATIVE Atopic dermatitis is an itchy, rash-inducing skin disease that affects around 10% of children and up to 3% of adults in the US. We have discovered that healing of skin wounds is altered in a model of atopic dermatitis. In this proposal, we investigate the mechanisms of this altered healing response by defining the role of specific soluble mediators and cells present in the skin.